Mapping Structural Brain Networks Linked to Mild Behavioral Impairment

Project Abstract
An estimated 6.7 million US adults live with Alzheimer’s disease (AD) and related dementias (ADRD); a figure
that is expected to more than double by 2060 unless new prevention strategies or treatments emerge.
Although later-life neuropsychiatric symptoms have been associated with a greater risk of dementia, they are
all too often viewed and treated as independent of ADRD. This traditional approach overlooks the possibility
that neuropsychiatric symptoms emerge due to AD/ADRD pathology build-up that drives structural changes in
brain regions or networks that differ from those affected by the more common “memory first” phenotype. Thus,
the proposed project leverages data from the National Alzheimer’s Coordinating Center (NACC) to evaluate a
recently developed mild behavioral impairment (MBI) diagnostic framework that standardizes the assessment
of neuropsychiatric symptoms in older adults during the pre-dementia phase(s). While MBI is typically linked
with regional atrophy of the medial temporal lobes, this is likely an overly simplistic view. Thus, our central
hypothesis is that MBI symptoms in early-stage clinical phenotypes (i.e., cognitively unimpaired and MCI) are
associated with structural changes within brain networks implicated in the processing and integration of
emotional experience--i.e., the salience and default-mode networks.
To test this, we will define the network-level structural alterations linked to MBI in early clinical phenotypes (Aim
1) and quantify the predictive value of MBI-related structural network changes for dementia conversion (Aim 2).
This is the first study to conduct a network-level analysis of the structural alterations associated with MBI in a
nationally representative cohort and link longitudinal trajectories of network-level structural changes in those
with MBI with the risk of conversion to dementia. Clarifying the neural correlates of MBI and their predictive
value for dementia conversion may help with early detection of “at-risk” individuals and understanding of
disease progression. These findings will pave the way for future studies integrating AD biomarkers and inform
the development of targeted interventions for specific brain regions implicated in MBI. The current project
aligns well with the NIA SCAN initiative to harmonize MRI data across AD Research Centers and will
strengthen my plan to pursue a K award focusing on individualized treatments for MBI.

Public health relevance
Project Narrative This research investigates Mild Behavioral Impairment (MBI), which could be an early indicator of Alzheimer's disease and related dementias. By understanding how MBI relates to changes in brain structure, the project aims to improve early detection and intervention strategies for dementia, potentially delaying its onset and enhancing the quality of life for those affected. This work is crucial for public health as it addresses a growing need for effective dementia care and prevention strategies.